Investigator Development Core (IDC)

INVESTIGATOR DEVELOPMENT CORE ABSTRACT
The Investigator Development Core (IDC) will provide a comprehensive career development program that will
accelerate the growth of junior faculty and early stage investigators (ESI) into independent investigators. The
IDC will implement a tri-faceted approach to investigator development that involves providing pilot seed-grant
support, coordinating comprehensive career mentoring that includes both discipline-specific research and
professional advancement mentoring, and offering professional development trainings relevant to early stage
investigators (e.g., grantsmanship, scientific presentation skills, and the elements and processes involved in
scientific writing). These three approaches are both feasible and effective for developing productive
investigators who are successful at securing external funding for basic biomedical, clinical, and/or behavioral
research on minority health and health disparities. The IDC represents a systematic and methodical program
for Howard University to fast-track the development of junior faculty and early stage investigators into
seasoned investigators. This tri-faceted approach covers the key areas that are most important to investigator
development and promises to become a model for the development of Howard investigators well into the
future. The IDC is a prescriptive response to an experiential institutional need. It should be noted that fulfilling
this institutional need will play an important role in positioning and solidifying Howard University’s role as an
important contributor and leader in minority health and health disparities research.